CPML - Core A: Administrative Core

ABSTRACT ? CORE A The administrative core for Center for Precision Medicine in Leukemia is co-led by the Co-principal investigators for this P50, Drs. Relling and Loh. The executive committee also includes Dr. Evans, Dr. Hunger, and Dr. Cheng. This is an interdisciplinary group of experienced basic, translational, and clinical investigators who have a proven track record of working together and meeting deadlines. They will work together to oversee the progress on all three projects and two cores to ensure that the Center’s milestones are set and met, and to facilitate interactions between the Center and external groups. The PI and Co-PI (Relling and Loh) are supported by administrative staff at SJCRH. The P50 Administrator, Dawn Bowen, has considerable experience in cancer center and grants administration. The Specific Aims of this essential core are: (1) To oversee, monitor, and prioritize internal progress of projects, cores and programs to ensure the Center is meetings its milestones. (2) To facilitate internal interactions among Center projects and cores. (3) To facilitate external outreach of the Center to the Pharmacogenomics Research Network (PGRN), the genomics community, the pediatric and adult ALL cooperative groups and other ALL clinical consortia, and the external genomics groups performing clinical implementation of pharmacogenomics and precision medicine. (4) To execute changes in emphasis and direction and devise contingency plans based on changing priorities over time. (5) To ensure outreach to, appointment of, interface with, response to, and planning of meetings with the External Advisory Board (EAB). (6) To coordinate Executive Committee conference calls, monthly web-based Center Work in Progress seminars, EAB interactions, and the annual Center Retreat. (7) To take a leadership role in the PGRN and program and organize a meeting of the PGRN. (8)To ensure timely data sharing and data deposits. (9) To manage budgetary issues and prepare progress reports.